Administrative Core

SUMMARY FOR ADMINISTRATIVE CORE
The Administrative Core will provide leadership, cohesion and logistics for the entire Yale ADRC to
achieve its goal of understanding the cellular basis of Alzheimer’s disease and translating this knowledge into
effective therapy. The Administrative Core will emphasize the use of emerging imaging and integrated omic
methodologies for translational science. The Yale ADRC will also strive to develop the careers of young
Alzheimer’s researchers and to share Biospecimens and clinical data with Alzheimer and Aging researchers at
Yale and within NIA-sponsored networks. The Administrative Core will organize regular meetings amongst
Core leaders and with External and Internal Advisory committees. The distinguished Internal Advisory
Committee will provide general advice, career mentoring and evaluate Development Project proposals. The
Development Projects will support innovative Alzheimer’s disease research and will be administered by the
Core with the dual goal of pushing the boundaries of Alzheimer research and aiding the development of New
Investigator careers.

Public health relevance
PROJECT NARRATIVE: Per the program announcement, the Cumulative Project Narrative has been included in the Overall Component, Other Project Information section.